EFFECT OF GLUCOCORTICOIDS ON ENERGY EXPENDITURE

This study seeks to extend previous observations of increased energy expenditure during long term hypercortisolemia states by addressing the hypothesis that an associated lipolysis is a principal mechanism for this response. Healthy subjects will be evaluated under cortisol associated hyperinsulinemia or euinsulinemia conditions by 2 separate infusion studies of overnight duration. This study will also seek to determine if any residual effect of hypercortisolemia status persists in these subjects.